Investigating the pathomechanisms underlying Charcot-Marie-Tooth Disease

PROJECT SUMMARY
Charcot-Marie-Tooth (CMT) disease is a genetically and clinically heterogeneous group of
inherited peripheral neuropathies that is characterized by damage to long motor and sensory
axons. The overall goal of this project is to identify the molecular and cellular processes that are
shared between different CMT genes to help address a common target for treatment for this
currently incurable disease. Our lab extensively studies aminoacyl-tRNA synthetases (aaRS),
the largest gene family involved in CMT, and discovered the nuclear function of one aaRS,
TyrRS, was shown to be associated to CMT pathogenesis while acting as a transcriptional
regulator under oxidative stress. Aim 1 sets out to understand how the nuclear aaRS function in
oxidative stress response plays a role in mouse physiology and if it is the commonality between
CMT-linked aaRS. Findings so far suggest nuclear TyrRS in mice leads to an increased
metabolism and disruption in the auditory system. This proposal sets out to perform a
longitudinal study to determine if the hearing loss is degenerative and where in the auditory
pathway there is a defect (e.g., sensory epithelium, spiral ganglion, brainstem, midbrain) while
also examining the molecular targets responsible using RNA-Sequencing on tissue samples.
Additionally, we uncovered that CMT-linked aaRS share a similar nuclear localization response
upon oxidative stress treatment in neuronal cells only. Aim 1 also sets out to investigate this
apparent cell type specificity, examine more cell lines, and evaluate the factor responsible for
the translocation property. More broadly, I want to understand the connection between multiple
CMT genes and subtypes to have a holistic view of the cellular organelles and signaling
pathways underlying CMT pathomechanisms. Therefore, in Aim 2 as a postdoctoral trainee I will
study a range of CMT proteins across subtypes of varying phenotypes. Patient derived, induced
pluripotent stem cells will be differentiated into two relevant CMT cell types for each mutant:
motor neurons and Schwann cells. Because there is evidence suggesting mitochondrial defects
and oxidative stress in some CMT subtypes, I will specifically investigate mitochondrial
morphology, dynamics, and function using imaging and cell-based assays, as well as, exploring
the levels of oxidate stress, stress-related damage, and potential pathways affected in CMT in a
cell type specific manner. During this proposal, activities such as teaching, writing workshops,
mastery of technical skills, and conference participation will be emphasized to equip me with the
professional development needed for an independent career in neuroscience.

Public health relevance
PROJECT NARRATIVE Charcot-Marie-Tooth (CMT) disease is the most commonly inherited peripheral neuropathy worldwide with over 100 genes involved, but with no cure. This research project sets out to examine the function of nuclear aminoacyl-tRNA synthetases and a range of other CMT genes to understand the connections in molecular pathways underlying CMT pathomechanisms to help guide therapeutic strategies.